IDO1 regulation of SR-BI and cholesterol homeostasis in macrophages

Inflammation is a fundamental biological process that plays key roles in immune response. However,
uncontrolled, and chronic inflammation are the root causes of many human diseases including metabolic
disorders, obesity, insulin resistance, diabetes, hypertension, and atherosclerosis. Macrophage activation plays
a central role in inflammation, regulates the host defense during pathogenic infection, and maintain tissue
homeostasis. Recent studies indicate that macrophage functions are influenced by lipid metabolism.10-15 The
imbalance in lipid uptake, metabolism, and removal in macrophages cause tissue trans-differentiation
contributing to hyperlipidemia and metabolic syndrome. For example, macrophages and derived foams cells are
the hallmarks of atherosclerosis. The signaling mechanism associated with lipid homeostasis and metabolism in
macrophages is complex and poorly understood. The primary goal of this proposal is to investigate the
cholesterol homeostasis mechanism in macrophages under inflammation. In particular, HDLR-SR-BI (SR-BI), a
receptor for the cholesterol-rich HDL, facilitates the selective delivery of HDL-cholesteryl ester to the liver. It
promotes atheroprotection via HDL metabolism. SR-BI is also expressed in in macrophages and regulates lipid
homeostasis. In a preliminary study, we observed that the SR-BI expression is downregulated in macrophages
upon LPS stimulation, and this is potentially regulated viaIndoleamine-2,3-dioxygenase 1 (IDO1). We found that
IDO1 and its down-stream catabolite, kynurenine (KYN), are also elevated in LPS-stimulated macrophages and
inhibition of IDO1 reversed the LPS-induced downregulation of SR-BI, suggesting potential role of IDO1 in SR-
BI expression and cholesterol homeostasis, in macrophages. Notably, KYN is a ligand for aryl hydrocarbon
receptor (AhR) which regulates genotoxic stress and inflammatory response. Here, we propose biochemical and
cell-based experiments to investigate the roles of IDO1 and KYN-AhR signaling in SR-BI expression and
cholesterol homeostasis, in macrophages (aim 1). In the aim 2, we propose to investigate the roles of IDO1 in
hepatic inflammation, Kupffer cells (resident macrophage in liver) activation, SR-BI expression, and cholesterol
homeostasis in vivo using ovariectomized (OVX) rat as animal model. Overall, our studies will lead to the
discovery of novel signaling pathways associated with SR-BI expression and cholesterol homeostasis in
macrophages under inflammation. In addition to addressing an important scientific problem, this proposal will
also serve to enrich student (especially undergraduates) research experiences at UTA, a minority-serving
institution.
1

Public health relevance
Macrophage dysfunction and chronic inflammation are the root cause of many human diseases including obesity, diabetes, insulin resistance, atherosclerosis, and cardiovascular diseases. Imbalance in lipid metabolism and homeostasis contributes to macrophage dysfunction. Here, we propose experiments to discover novel regulators of inflammation associated macrophage activation and cholesterol hemostasis that may lead to the discovery of potential biomarkers, and therapeutic targets for the treatment of chronic inflammatory human diseases. 1